Promoting Palliative Care for People with Heart Failure: The P3HF Pilot Study

Project Summary
Heart failure is a leading cause of morbidity and mortality, projected to affect more than eight million Americans
by 2030. Frequent symptoms, hospitalizations, and hospital readmissions are common among this population,
causing significant suffering, particularly near the end of life. Conversations about prognosis, the benefits and
harms of invasive treatments, and patient care goals and preferences are essential to promote goal-
concordant care among this population. Yet, these conversations occur infrequently. To address these critical
needs, the American Heart Association, the American College of Cardiology, and the Heart Failure Society of
America recommend palliative care as a Class I (strong) recommendation “for all patients with heart failure to
improve quality of life and relieve suffering.” However, fewer than 20% of this population receive Specialist
Palliative Care. Patient prognosis is a key criterion for referral to palliative care among this population. Our
team developed and validated an automated electronic health record-based 1-year mortality risk model for
people hospitalized with heart failure and embedded the model into an interruptive alert to facilitate clinician
decision-making. While the alert was highly accurate, acceptable, and feasible among clinicians, it did not
result in a significant increase in referrals to Specialist Palliative Care in a subsequent clinical trial. Interruptive
alerts deliver the right information but often at the wrong time, resulting in clinician overrides and task
abandonment. Non-interruptive clinical decision support (CDS), such as targeted modal alerts and passive
designs, provides innovative alternatives to interruptive alerts. However, their effectiveness hinges on careful
user-centered design and the development of strategies for implementation. Thus, our overall objective is to
design and pilot test the Promoting Palliative Care for People with Heart Failure (P3HF) CDS, a tool that
incorporates our 1-year mortality alert with evidence-based CDS design, and critically, pairs the CDS with
strategies for implementation. To accomplish our objectives, we will design the P3HF CDS and develop an
accompanying implementation package using a theory-informed process involving interviews, iterative design,
and focus-group-led evaluation with healthcare provider stakeholders (Aim 1). Next, we will conduct a
randomized real-world pilot trial across two hospitals to evaluate the usability, acceptability, appropriateness,
and feasibility of the P3HF CDS and implementation package. We will also examine the intervention's
preliminary efficacy on clinician behavior change (i.e., referral to Specialist Palliative Care, primary outcome)
and patient outcomes (i.e., Advance Care Plan documentation, hospice enrollment, hospital length of stay, 30-
day hospital readmission, exploratory secondary outcomes; Aim 2). This study will provide essential data
necessary and sufficient to inform a subsequent multi-site hybrid efficacy-effectiveness clinical trial of the P3HF
CDS and implementation package. If successful, this project will result in an evidence-based, generalizable
intervention that could greatly improve care delivery and quality of life for people with heart failure.

Public health relevance
Narra�ve This project will develop and test a novel clinical decision support tool that encourages timely referral to palliative care for people hospitalized with heart failure. This clinical decision support intervention will deliver prognostic information and evidence-based decision support at the point of care. Thus, this research may lead to improved care-concordant and goal-directed care for people with heart failure.